Mechanism of the Human Telomere C-Strand Fill-In Machinery Assembly and Activation at Chromosome Ends

Project Summary/Abstract
Telomeres are specialized nucleoprotein structures that protect chromosome ends and confer genome stability
in eukaryotic cells. Without telomeres, chromosomes undergo misguided end-to-end fusions, leading to
chromosomal aberrations and eventual genome instability. Hence, deregulation of telomere maintenance
results in human diseases such as cancer and dyskeratosis congenita. The human telomeric DNA comprises
thousands of tandem repeats of the conserved hexameric sequence, TTAGGG. The telomeric DNA has a
unique structure, a several kilobases long double-stranded DNA (dsDNA) region that ends with a 3' single-
stranded DNA (ssDNA) overhang. The cornerstone of telomere maintenance is the two-part process of
telomeric DNA synthesis. In the first step, the ribonucleoprotein telomerase extends the telomere G-rich 3'
overhang. Telomerase adds telomeric repeats to the ssDNA overhang. Next, telomeric ssDNA-binding protein
complex, CTC1-STN1-TEN1 (CST), coordinates with DNA polymerase alpha-primase (Polα-primase) to fill in
the newly-synthesized telomeric G-overhang by de novo C-strand synthesis. While the mechanism of the
extension of telomeric G-overhang by telomerase is an area of intense study since the discovery of telomerase
almost four decades ago, that for the telomeric C-strand fill-in by CST-polα-primase is much less understood.
Telomere C-strand fill-in is equally essential in telomere maintenance as the G-overhang extension process. As
such, this proposal aims to study the molecular mechanism of the human telomere C-strand fill-in machinery
by providing biochemical and structure-function relationship understandings of template-bound CST-Polα-
primase at key catalytic steps. Multiple novel models and hypotheses from this proposal are based on the
premises of our recent cryogenic-electron microscopy (cryo-EM) structures of the human template-bound CST-
Polα-primase preinitiation complex (PIC). For the first aim, we will establish an unprecedented consensus
template sequence for CST-Polα-primase assembly and C-strand synthesis initiation. For the second aim, we
will use cryo-EM single-particle analysis to determine the structural basis of how CST-Polα-primase initiates de
novo RNA primer synthesis after PIC assembly at telomeric overhangs. For the third aim, we will elucidate the
molecular mechanism of how CST-Polα-primase “counts” the RNA primer length during synthesis and promptly
terminate the “matured” RNA primer for the intramolecular primer handover to the DNA polymerase domain.
The findings from this proposed work will provide a timely advancement to our understanding of the human
telomere C-strand fill-in mechanism and mammalian telomeric DNA synthesis in general. The proposal
structure-function studies provide a missing platform to connect CST and Polα-primase human disease
mutations to mechanistic understandings. From a broader perspective, telomere C-strand fill-in is an excellent
model for studying lagging-strand synthesis by Polα-primase in replisomes.

Public health relevance
Project Narrative Telomeric DNA synthesis is the cornerstone of telomere maintenance, which, if deregulated, leads to human diseases such as cancer and premature aging. While the mechanism of the initial part of telomeric DNA synthesis – telomere G-overhang extension by telomerase – is well understood, the subsequent telomere C- strand fill-in process is much less known. This proposal seeks to establish how the human telomere C-strand fill-in machinery assembles at telomeric G-overhangs and builds the complementary C-strand.